Assembly, Dosimetry, and Assessment of a Platform Technology for the Delivery of Thrombolytics

Project Summary
The proposed research seeks to validate and extend a platform technology for the
delivery of protein-based drugs, which includes application to current and next generation
therapeutics. The bioengineering strategy employs the designed assembly of
endogenous biomolecules, namely thrombolytic enzymes and vitamin B12, as well as
cell-based transport and delivery to create a biocompatible drug delivery platform. The
drug delivery technology uses the circulatory system as a natural drug depot, is drug
agnostic, releases the protein therapeutic at the diseased site in a photon-targeted
fashion, and is 25-fold more effective than the standard of care in our preliminary in vivo
studies. The wavelength of drug release is readily assigned at the molecular level. The
following issues will be addressed: (i) accommodation of an array of thrombolytic proteins
that operate by distinct mechanisms; (ii) multi-drug synergism of thrombolysis (iii)
responsiveness to deep tissue penetrating photons; (iv) delivery efficacy as a function of
irradiation parameters, melanin and body mass index, and sex; and (v) therapeutic
efficacy and safety under conditions in which therapy is contraindicated.

Public health relevance
PROJECT NARRATIVE Pulmonary embolism (PE) is the third most common cause of cardiovascular death in the United States, the second most frequent cause of death among cancer patients and is responsible for 9% of all pregnancy related deaths. We’ve developed a photothrombolytic drug delivery system that is more effective than conventional clot busting therapies at a 25-fold lower dose. We’ll employ the distinctive spatial, temporal, and dosing flexibility associated with photothrombolytics to identify the maximally effective drug dose with a focus on reducing/eliminating the life threatening side effects associated with systemic thrombolytic drug therapy.